Integration of platelets and coagulation to maintain hemostasis in vivo

Project summary
Despite therapeutic advances, patients with impaired coagulation face persistent risks of acute bleeding and
chronic tissue damage. Current treatment strategies focus on enhancing thrombin generation, including new
therapeutics targeting endogenous anticoagulant pathways. These "hemostasis rebalancing" strategies have
shown promise in clinical trials, with potential benefits over factor replacement or bypassing agents. Building on
this concept, our proposed studies explore whether hemostatic rebalancing can be achieved by suppressing
negative internal regulators of platelet signaling to enhance platelet activation. Preliminary data demonstrate that
reduced thrombin production in the context of coagulation deficiency limits platelet-mediated hemostatic plug
stability. Genetic disruption of GPCR receptor kinase (GRK) family members, which typically limit platelet
reactivity, enhances platelet activation and reduces bleeding in a hemophilia model, even without restoring
coagulation factor levels. Thus, we hypothesize that targeting GRKs and other platelet signaling regulators will
rebalance hemostasis and attenuate bleeding in coagulation disorders. We will explore this hypothesis in two
Aims. First, we will investigate the role of reduced platelet activation in the pathologic bleeding associated with
coagulation disorders. Our studies will determine the mechanisms by which thrombin-mediated platelet activation
contributes to the maintenance of hemostasis over time. Second, we will investigate the effect of increasing
platelet reactivity on hemostatic plug structure and function in contexts of pathologic bleeding. The effect of
platelet-specific GRK deficiency on platelet function in normal and hemophilic mice will be determined, as will
the effect of pharmacologic GRK antagonism on human blood from healthy donors and hemophilia patients. We
will also investigate the prothrombotic potential of platelet sensitization in contexts of coagulation deficiency. The
comprehensive research strategy proposed will include state-of-the-art imaging to analyze hemostatic plug
structure and function in vivo in mouse models, as well as microfluidic flow chamber studies to assess human
blood in vitro. Overall, these mechanistic and translational studies aim to establish a proof of concept that
enhancing platelet activation is an effective hemostasis rebalancing strategy to mitigate bleeding when
coagulation is impaired.

Public health relevance
Project Narrative The coagulation system and platelets work together as part of the normal response to vascular injury, called hemostasis, producing a plug that limits blood loss. Disruption of the hemostatic system in pathologic settings can result in many clinical problems, including excessive bleeding (e.g. hemophilia). The goal of this project is to better understand how coagulation and platelets interact to produce an optimal response to injury, and translate that understanding into improved methods to treat disorders of the hemostatic system.